Identification of distributed neural sources of the auditory steady-state response in psychosis Biotypes

The auditory steady-state response (aSSR) is a promising translational biomarker for psychosis. Entrainment to
different frequencies of stimulation engage unique neural generators and cortical circuitry. Auditory 40-Hz
gamma responses have been preferentially proposed as a schizophrenia biomarker. In a sample of over 500
total observations, with subjects across the psychosis spectrum (schizophrenia, schizoaffective disorder, bipolar
disorder with psychosis) we did not find any aSSR measure that was unique to any DSM psychosis syndrome.
Alternatively, neurobiologically defined psychosis subgroups (psychosis Biotypes) have unique and
differentiating aSSR features. The type and extent of these differences were associated with level of cognition,
independent of psychosis. In this proposal, we will use multimodal neuroimaging with electroencephalography
(EEG), magnetoencephalography (MEG), and structural magnetic resonance imaging (sMRI) to investigate
neural source distribution of the aSSR at multiple frequencies (20-, 40-, and 80-Hz) in psychosis cases with
either deficient (psychosis Biotype-1; n=35) or exuberant (psychosis Biotype-2; n=35) neural responses to the
aSSR. Both of these subgroups have poor cognition. Rather than comparing them to a mixed health group,
healthy individuals will be subdivided by cognitive control (high or low, n=35 of each subgroup). The low cognitive
control group will be similar to the psychosis cases on cognition but without psychosis symptoms. EEG and MEG
recordings will be used to detect radial and tangential neural sources of initial auditory registration and the aSSR
with high temporal resolution. EEG, with its sensitivity to both radial and tangential neural sources, will provide
a link to the majority of the previous literature on this topic, while MEG, with its excellent ability to measure
auditory neural signals, will yield complimentary information about the mostly tangential neural sources of the
aSSR. These measures will be used to examine the distributed neural activity of the aSSR from beta to high
gamma frequencies, and how they differ as a function of psychosis subtype and cognitive control abilities.
Hypotheses: (1a) Biotype-2 cases will have exuberant neural activity as measured by single trial power (STP) in
primary auditory cortex; (1b) Biotype-2 cases will show exuberance of their STP response in distributed cortical
regions that will be more extensive in gamma frequency ranges; (1c) Biotype-1 cases will have reduced
amplitude responses in primary auditory cortex and no evidence of a more distributed cortical response pattern
on STP; (2a) High cognitive control healthy persons will differ from all other groups on ITC and the magnitude of
its local (auditory cortical) and distributed neural sources, especially as stimulation frequency increases into the
high gamma range; (2b) Low cognitive control healthy persons will not differ from the psychosis groups on ITC
in auditory cortex, but will differ on magnitude of ITC sources outside of auditory cortex. This project will clarify
psychosis-specific from general cognition-related features of aSSR and support a path to better etiological
studies that are not currently possible using conventional diagnoses.

Public health relevance
PROJECT NARRATIVE The auditory steady-state response (aSSR) is a promising translational biomarker for psychosis. Identifying unique neural sources of aSSR deficits in psychosis will provide specific targets for future clinical and pharmacological interventions. This study will use multi-modal neuroimaging to examine specific types of psychosis cases (psychosis Biotypes) to identify neural deviations that are specifically related to psychosis and its unique clinical and neurobiological manifestations.